Admin-Core

ABSTRACT – Admin Core
The Administrative Core will support research, core, and mentoring activities in collaboration with Makerere
University Lung Institute (MLI), Uganda Cancer Institute, Joint Clinical Research Centre (JCRC), Mulago
National Specialized Hospital (MNSH), National Institute for Medical Research (NIMR), Muhimbili Centre, Ocean
Road Cancer Institute, and the Case Comprehensive Cancer Center (Case CCC) of Case Western Reserve
University (CWRU). Administrative support for the collaboration entails overseeing and managing the
coordination of scientific meetings, communication between the US, Uganda and Tanzania, progress reports,
and presentations. Communication and meeting planning will be managed by experienced staff at the Case
CCC which has developed strategies for effective implementation. Annual meetings will be organized with
parallel administrative roles at the JCRC in Uganda and NIMR in Tanzania. All communication will be planned
carefully to maximize time and resources. It is anticipated that the consortium travel budget will support 6-7
project directors and core directors annually.

Public health relevance
RELEVANCE – Admin Core The Administrative Core supports the goals of this U54 proposal by facilitating implementation of scientific communication, resources, and interaction between all projects, cores, and early career investigator developmental projects interrogating the underlying biology of HIV-1 infection and the causal relationship to lung cancer. The Administrative Core provides the assistance to facilitate technological equipment transfer to Uganda for lung cancer somatic mutation analysis and for DNA methylome analytics at the Joint Clinical Research Center in Kampala to which Tanzanian samples will also be sent for molecular analysis.